Regional Centre for Vector Borne Diseases in West Africa (RCVBD)

PROJECT SUMMARY
Although West Africa is currently burdened with an unprecedented high levels of malaria, the research
capacity in Africa is too low to meet the malaria control and elimination goal. Furthermore, many new
techniques and tools developed in the developed countries have not been well utilized by Africa
scientists. For example, new tools in molecular population genetics, genomics and bioinformatics and
disease modeling have not been integrated into malaria research and control in Africa. Low research
capacity in West Africa is far more dire in comparison to other African regions. Therefore, there is an
immediate need to strengthen the research capacity in infectious diseases in West Africa. We propose
this Regional Centre for Vector Borne Diseases in West Africa (RCVBD) to enhance research capacity
in malaria epidemiology and medical entomology through training PhD students and junior faculty and
research scientists. The consortium partners are from three West African institutions (University of
Ghana, The Medical Research Council Unit Gambia, and Institut de Recherche en Sciences de la
Santé of Burkina Faso). Collaborators from three US institutions (University of California at Irvine,
University of New Mexico and the Northwestern University) will assist the training program. The overall
goal of this training program is to enhance research capacity in West Africa by training the next
generation of African scientists in the area of vector-borne disease research and control with a
special focus on malaria. The thematic areas of training include epidemiology, medical entomology
and application of new genetic, genomic and ecological research tools. We propose three tracks of
training. Track 1 will be long-term training of 8 PhD students in West Africa. Track 2 will provide short-
term research training to 15 junior university faculty and junior scientists from the Ministry of Health in
West Africa to foster specific skills required for malaria research and control. Track 3 will be training
workshops and short courses to disseminate techniques and knowledge to wide communities involved
in vector borne disease research and control in West Africa. This training program will focus on four
scientific areas in urgent need, including 1) new tools for malaria epidemiological and entomological
surveillance, 2) antimalarial drug resistance to artemisinin and partner drugs, 3) population genomics
of insecticide resistance, and 4) modeling malaria transmission dynamics and malaria intervention
strategies. This research training program will help advance the careers of West African scientists by
strengthening their academics and research productivity through vigorous mentorship and outstanding
publications, equipping them with new knowledge and skills, and enhancing their collaborative
opportunities with scientists within and out of Africa.

Public health relevance
Project Narrative West Africa is highly burdened with several vector-borne diseases, especially malaria, yet have very little research capacity, therefore, this training program offers the chance for a multi-site training of PhD and junior scientists/faculty who will become future research leaders. The proposed program will lead to the building and strengthening of local investigator capacity. Successful malaria and other vector-borne diseases control needs capacity building in disease endemic countries to establish a cadre of local scientists who can address the ongoing and evolving challenges in vector-borne diseases and control.